Spatiotemporal Regulation of Organelle Interactions and Metabolism

ABSTRACT
Metabolic diseases are a pressing public health issue in the United States. With the meteoric rise of insulin
resistance, obesity, and atherosclerosis, mechanistic understanding of lipid metabolism could not be more
imperative. Many of these metabolic disorders involve improper storage of lipids into cellular lipid storage
organelles known as lipid droplets (LDs). These unique organelles, which contain a core of triglycerides (TAGs)
and other neutral lipids, accumulate when dietary free fatty acids are abundant but are consumed when there is
a high demand for energy. Although the metabolic roles of LDs are well appreciated, the mechanisms employed
to regulate the growth and catabolism of individual LDs are poorly understood. It has emerged that protein
networks that reside on the surface of LDs play critical roles in controlling the release of the lipids stored within.
We have previously found that a protein that drives physical contacts between the ER and LDs, DFCP1, plays a
key regulatory role in modulating the activity of adipose triacylglycerol lipase (ATGL) the rate limiting enzyme in
LD catabolism. Specifically, we found that DFCP1 recruits and sequesters ATGL on the LD surface - even under
conditions that promote the activation of ATGL - such as phosphorylation by energy sensing kinases, AMPK and
PKA, or by interacting with cofactor CGI-58. Ablating DFCP1 from cells or forcing DFCP1 to disassemble from
LDs leads to a dramatic increase in ATGL dynamics and lipolysis. Under these conditions, LD turnover is greatly
accelerated leading to rapid breakdown of LDs and a surplus of free fatty acids in cells. Owing to the importance
of this interaction, we found that ablation of DFCP1 from stem cells leads to changes in mitochondrial activity
and lipid metabolism that ultimately leads to severe impairment of the ability of cells to differentiate. How DFCP1
specifically, and ER contact sites in general regulate lipid metabolism is not well understood, much less the roles
these proteins serve in stem cell metabolism during differentiation. To address these gaps in our understanding
of LD lipolysis, we are using bottom-up approaches to biophysically and structurally define how lipolytic
complexes are assembled and regulated by protein networks on the LD surface. We will also employ novel
optical biosensors to examine how organelle interactions correlate with metabolism and to define how LD contact
site proteins regulate LD interactions with other organelles. Finally, we will examine how disruption of these LD
contact site proteins and regulators of LD lipolytic complexes impairs the regenerative and differentiation capacity
of stem cells. The mechanistic insight obtained by these studies will provide new understanding into how LD
metabolism is regulated and helps to maintain cellular homeostasis, as well as how this process can be controlled
to improve stem cell health and tissue regeneration.

Public health relevance
PROJECT NARRATIVE Lipid droplets are specialized transient organelles that serve as reservoirs of neutral lipids that can be tapped to resupply the cell with energy and lipids. Improper storage of lipids is the hallmark of metabolic diseases. The proposed research will elucidate the molecular mechanisms that lipid droplet proteins use to regulate lipid metabolism, as well as how impairing these mechanisms impact energy homeostasis, regeneration of tissues and contribute to lipid storage diseases.